Pathological Autoantibodies Contribute to Immune Suppression in Sepsis

PROJECT SUMMARY/ABSTRACT
Sepsis is a severe illness associated with high morbidity and mortality in the US and globally. Complications of
multi-organ dysfunction, acute respiratory distress syndrome, and infections have a significant impact on late
survival. With limited therapeutic interventions, it is essential to understand the fundamental biology of sepsis.
Immune dysfunction and immunosuppression are characteristic of sepsis, especially with late complications
where lymphopenia predicts a poor prognosis. Gaps remain, however, in the understanding of the
mechanisms underlying prolonged immune suppression. Recently, there has been a greater appreciation of
autoimmune antibodies that lead to pathological immune consequences in the setting of critical illness. For
example, sepsis due to COVID-19 leads to anti-cytokine autoantibodies (ACAAs) that correlate with greater
disease severity. In our preliminary data we have also defined ACAAs post-COVID along with ACAAs in ICU
patients with sepsis. We have also made the novel discovery of anti-Fas autoantibodies (FasAAs) induced
during sepsis, representing a novel mechanism for lymphopenia associated with critical illness. Our
overarching hypothesis is that severe conditions like sepsis induce pathological autoimmunity that
alters immune function and increases infections. Our hypothesis predicts that sepsis patients with higher
levels of autoantibodies will have more immune dysregulation and secondary infectious complications. The
objective of this proposal is to determine the prevalence of ACAAs, define mechanism(s) by which they
contribute to immunosuppression, and identify sites where their activity could be disrupted for therapeutic
purposes. We propose using complementary immune and computational approaches to identify
autoantibodies from the blood of sepsis patients and how they correlate with clinical status. We will investigate
the biological function of these antibodies on human cytokines and human cells in vitro, along with developing
strategies to interfere with deleterious autoantibodies. To address these issues, we have obtained over 350
serum specimens for this study to discriminate between the effects of preexisting autoantibodies and those
with a net increase during sepsis. In addition, we have access to deep RNA-seq data from over 100 sepsis
patients for computational studies. The long-term objective is to apply this information to assess prognosis of
sepsis patients and create precision therapeutics to sustain and restore immune function.

Public health relevance
PROJECT NARRATIVE Mortality after sepsis is associated with suppression of the immune system and an increased risk of infection. This research investigates a novel mechanism of immune suppression that is associated with critical illness, namely antibodies against self-proteins in the immune system. Armed with this information, a new therapeutic modality will be developed to preserve the immune system in patients with severe illnesses like sepsis.